(2/2) Pacific Island Partnership for Cancer Health Equity (PIPCHE)

Specific Aims
This supplement application addresses the need to better prepare researchers in Guam and
Micronesia, particularly in data science, so they can pursue careers in cancer health disparities and other
biomedical fields. Pacific Islanders are extremely underrepresented in the nation’s biomedical workforce, both
on the faculty of universities and research institutions as well as in hospitals and public health departments.
The limited number of Pacific Islanders with graduate degrees continues to impede progress in research and
prevention of cancer health disparities. The Pacific Island Partnership for Cancer Health Equity (PIPCHE) is
the National Cancer Institute’s only U54 partnership that advances cancer health equity in Pacific Islands
Populations (PIP). PIPCHE’s overarching goal is to promote cancer health equity and mitigate the impact of
cancer on PIP through increasing cancer research leadership and capacity in Hawai‘i, Guam and the USAPI.
The University of Guam (UOG) is the minority-serving institution (MSI) within PIPCHE and is a USDA land-
grant institution whose student population is 90% Asian Pacific Islander, of whom 51% are native Pacific
Islanders. UOG is uniquely situated to recruit and inspire future professionals from these Pacific Islander
groups as well as conduct research with the diverse communities living in Guam and other Micronesian
islands.
The current goal of PIPCHE’s Research Education Core (REC) is to train graduate students committed
to addressing health disparities in Pacific indigenous populations. Despite the success of the PIPCHE-REC in
training PIP students to pursue and complete graduate degrees, there remains a dearth of researchers
competent in data science in Guam. Additionally, UOG has limited faculty with expertise in math, statistics, and
data science, all burdened with full teaching schedules. Furthermore, UOG graduate students funded by
PIPCHE-REC extensively utilized PIPCHE's Biostatistics Shared Resource (BSR) for thesis project data
analysis due to their limited experience in statistics and data science. A new graduate program in Data
Science has been developed at UOG, which would equip students with the technical skills to collect, manage,
analyze, and interpret data, and will also be proficient in programming languages such as R and Python, and
statistical analysis tools such as SAS and SPSS. The anticipated start of the program is Fall 2024.
The proposed supplement seeks to support the establishment of a Data Science Center at the UOG,
designed to complement the MS in Data Science program and bolster the region's data science capabilities.
Integral to this program is the mandatory capstone course entitled "Statistical Research and Consulting."
Within this course, students will undertake internships at the Data Science Center, engaging in collaborative
projects with UOG researchers or partnering with government agencies. The Center will serve as a hub for
additional support, offering students enhanced opportunities to gain valuable research skills and practical
experience.
As part of this initiative, we aim to enhance UOG's data science capabilities by upgrading our
infrastructure with high-performance workstations and developing a comprehensive cancer database. We
intend to investigate the feasibility of linking the Guam Cancer Registry (GCR) with data from Guam's
Medicare, Medicaid, and Medically Indigent Program (MIP) recipients. This integrated dataset is expected to
be a valuable resource for researchers. Furthermore, we plan to forge partnerships with regional community
colleges to offer summer data science workshops.
Aim 1: Establish the first regional Data Science Center in synergy with the MS in Data Science at UOG.
The center will provide research support and advance education in data science in Guam and Micronesia.
Aim 2: Establish infrastructure, security protocols and agreements necessary for the data linkage
between Guam Cancer Registry and Medicare, Medicaid and MPI. The linkage would improve the
completeness of GCR treatment data and will be the source for future studies, for example adherence to
treatment and its impact on survival.
Aim 3: Build data science education and training partnerships with the Northern Marianas College
(NMC) and Palau Community College (PCC). These partnerships will enhance data science knowledge and
skills of the researchers and students in NMC and PCC and create the pipeline for the data science path at
UOG.
We hypothesize that the establishment of the Data Science Center will significantly increase the number of
underrepresented students, particularly Pacific Islanders, trained in statistics and data science.
Impact: This supplement will greatly enhance the research and data science capacity of UOG, Guam and the
greater Micronesian region. Students trained in the proposed program would be equipped with the necessary
skills to work as data analysts in both academic, healthcare, and industry settings.

Public health relevance
PROPOSAL TITLE: Establishing UOG Data Science Center. INVESTIGATORS: Rachael Leon Guerrero (PI), Yvette Paulino (PI), Grazyna Badowski (Co-I), Leslie Aquino (Co-I) Project type: Administrative Supplements to Enhance Institutional Data Science Capacity. NOT-OD-23-123 Specific Aims This supplement application addresses the need to better prepare researchers in Guam and Micronesia, particularly in data science, so they can pursue careers in cancer health disparities and other biomedical fields. Pacific Islanders are extremely underrepresented in the nation’s biomedical workforce, both on the faculty of universities and research institutions as well as in hospitals and public health departments. The limited number of Pacific Islanders with graduate degrees continues to impede progress in research and prevention of cancer health disparities. The Pacific Island Partnership for Cancer Health Equity (PIPCHE) is the National Cancer Institute’s only U54 partnership that advances cancer health equity in Pacific Islands Populations (PIP). PIPCHE’s overarching goal is to promote cancer health equity and mitigate the impact of cancer on PIP through increasing cancer research leadership and capacity in Hawai‘i, Guam and the USAPI. The University of Guam (UOG) is the minority-serving institution (MSI) within PIPCHE and is a USDA land- grant institution whose student population is 90% Asian Pacific Islander, of whom 51% are native Pacific Islanders. UOG is uniquely situated to recruit and inspire future professionals from these Pacific Islander groups as well as conduct research with the diverse communities living in Guam and other Micronesian islands. The current goal of PIPCHE’s Research Education Core (REC) is to train graduate students committed to addressing health disparities in Pacific indigenous populations. Despite the success of the PIPCHE-REC in training PIP students to pursue and complete graduate degrees, there remains a dearth of researchers competent in data science in Guam. Additionally, UOG has limited faculty with expertise in math, statistics, and data science, all burdened with full teaching schedules. Furthermore, UOG graduate students funded by PIPCHE-REC extensively utilized PIPCHE's Biostatistics Shared Resource (BSR) for thesis project data analysis due to their limited experience in statistics and data science. A new graduate program in Data Science has been developed at UOG, which would equip students with the technical skills to collect, manage, analyze, and interpret data, and will also be proficient in programming languages such as R and Python, and statistical analysis tools such as SAS and SPSS. The anticipated start of the program is Fall 2024. The proposed supplement seeks to support the establishment of a Data Science Center at the UOG, designed to complement the MS in Data Science program and bolster the region's data science capabilities. Integral to this program is the mandatory capstone course entitled "Statistical Research and Consulting." Within this course, students will undertake internships at the Data Science Center, engaging in collaborative projects with UOG researchers or partnering with government agencies. The Center will serve as a hub for additional support, offering students enhanced opportunities to gain valuable research skills and practical experience. As part of this initiative, we aim to enhance UOG's data science capabilities by upgrading our infrastructure with high-performance workstations and developing a comprehensive cancer database. We intend to investigate the feasibility of linking the Guam Cancer Registry (GCR) with data from Guam's Medicare, Medicaid, and Medically Indigent Program (MIP) recipients. This integrated dataset is expected to be a valuable resource for researchers. Furthermore, we plan to forge partnerships with regional community colleges to offer summer data science workshops. Aim 1: Establish the first regional Data Science Center in synergy with the MS in Data Science at UOG. The center will provide research support and advance education in data science in Guam and Micronesia. Aim 2: Establish infrastructure, security protocols and agreements necessary for the data linkage between Guam Cancer Registry and Medicare, Medicaid and MPI. The linkage would improve the completeness of GCR treatment data and will be the source for future studies, for example adherence to treatment and its impact on survival. Aim 3: Build data science education and training partnerships with the Northern Marianas College (NMC) and Palau Community College (PCC). These partnerships will enhance data science knowledge and skills of the researchers and students in NMC and PCC and create the pipeline for the data science path at UOG. We hypothesize that the establishment of the Data Science Center will significantly increase the number of underrepresented students, particularly Pacific Islanders, trained in statistics and data science. Impact: This supplement will greatly enhance the research and data science capacity of UOG, Guam and the greater Micronesian region. Students trained in the proposed program would be equipped with the necessary skills to work as data analysts in both academic, healthcare, and industry settings. RESEARCH STRATEGY Background and Significance A new graduate program in Data Science has been proposed at UOG with the anticipated start in Fall 2024. This 30-credit, cohort-based graduate program aims to equip students with skills in statistical modeling, machine learning, optimization, and big data analysis, catering to the urgent demand for data science professionals. The program's relevance is highlighted by the critical role of data analytics in public health, especially evident during the COVID-19 pandemic when a UOG math student contributed to analyzing COVID data for public health efforts. This new program addresses the need for experts who can harness data for impactful decisions, signaling a significant advancement in local and regional education and workforce development. The MS in Data Science program at UOG could draw students from various disciplines, including Mathematics, Computer Science, Biology, Chemistry, Health Science, and Psychology. Table 1 details enrollment numbers and degrees granted in these fields at UOG in recent years. Additionally, a preliminary survey was conducted among seniors and recent graduates to gauge interest in the forthcoming Academic year Health Science +Psychology 250 228 215 230 2018 2019 2020 2021 Declared Majors Math+CS+Biology +Chem 406 406 379 332 Number of Degrees Granted Math+CS+Biology +Chem 60 66 77 62Health Science +Psychology 43 51 40 31 Data Science program. Out of 53 student respondents, 66% expressed high interest in enrolling in the program. Until recently, students from Guam, PIPCHE biostatistics trainees, had to travel to the mainland U.S. to pursue their graduate degrees. While they have been successful, most have not returned to Guam. For instance, Louis Dulana, who earned an MS in Applied Statistics from Loyola University Chicago in 2021, is now a Behavioral Health Research Analyst with the Oregon Health Authority. Dwight Sablan, who earned MS in Data Science at the University of Washington in 2022, works as a computer scientist for the Air Force. Regina- Mae Dominguez, who completed her MS in Data Science at the University of Washington in 2023, works as a Data Analyst at the Institute for Health Metrics & Evaluation in Seattle, WA. The new program, which includes an internship at the Data Science Center, aims to prevent this brain drain by retaining talented students in Guam to pursue their graduate degree. Current trainees in the PIPCHE Biostatistics program have focused on analyzing Guam Cancer Registry Data (GCR), particularly looking into incidence trends (1) and survival analysis (2). They observed ethnic disparities in cancer incidence and survival rates in Guam. Specifically, CHamoru and Other Micronesians have the lowest 5-year survival rates for lung cancer, at 15.6% and 18.7% respectively. For breast cancer, Other Micronesian women have the lowest 5-year survival rate at 55.9%, with CHamoru women following at 81.1%. However, the analyses are primarily descriptive due to limitations in the GCR data. The GCR is affiliated with both the North American Association of Central Cancer Registries (NAACCR) and the US Pacific Regional Central Cancer Registry and adheres to the stringent data quality standards established by the NAACCR and the NCI SEER programs. The GCR includes comprehensive demographic, tumor, and survival data for all diagnosed cancer cases in Guam (3). However, the data on risk factors (smoking, drinking, BMI) and treatment information are mostly missing. For example, the treatment data for breast cancer cases is incomplete, with missing values ranging between 41% for diagnostic procedures and 58% for radiation therapy. Without the risk factors and treatment data it is impossible to investigate underlying causes for the disparities in cancer outcomes. In 1991, a collaboration between the National Cancer Institute (NCI) and the Centers for Medicare and Medicaid Services (CMS) enabled the linkage of NCI's Surveillance, Epidemiology, and End Results (SEER) cancer registry data with Medicare's enrollment and claims data, creating the SEER-Medicare database. Due to the significant interest in the cancer research community, the NCI, CMS, and SEER registries agreed that the NCI should oversee the database, ensuring its availability to researchers upon meeting confidentiality requirements. Today, the SEER-Medicare database remains a vital tool for evaluating cancer care and outcomes in the United States (4, 5). The Guam Cancer Registry (GCR) is not linked with Medicare because it is not a part of the SEER registry. According to the 2020 Guam Census, 20.2% of the population lives below the poverty level, 23.2% do not have health insurance, and the median household income is $58,289. Medicaid and Medicare programs are available in Guam, and there is also a locally funded Medically Indigent Program (MIP) designed to pay for medical expenses of low-income families without health insurance. Approximately 24% of Guam’s population was enrolled in Medicaid at the end of 2018. Obtaining Medicare’s enrollment and claims data will enrich the Guam Cancer Registry by incorporating not only treatment information but also social determinants of health which are important factors for understanding cancer treatment outcomes and survival disparities (6, 7). This integrated dataset will serve as a significant resource for researchers and students. Pacific Islanders, specifically Micronesians, are not only a small ethnic minority but highly underrepresented in STEM the biomedical research community. A survey of PhD degrees awarded in biological sciences in a one-year period in the US showed that not a single Pacific Islander received a PhD (Science, Vol 311, p 378, 2006), a dire problem that we have successfully started to address with PIPCHE. Moreover, a recent report by the National Commission on Asian American and Pacific Islander Research in Education (published by Educational Testing Service (ETS) in 2013), showed that, in contrast to the US average, educational attainment of the younger generation of Pacific Islanders is lower than that of their parents, and that the gap between the US average and Pacific Islanders widens. The UOG is characterized by a very high percentage of minority students (approximately 90%), almost all of whom are CHamorus and other Micronesians. The UOG is the only minority institution in the country where Pacific Islanders constitute the majority of the student body. Yet, there is no established pathway for students from regional community colleges to transition to UOG. Very small number of students from Northern Marianas College (NMC) and Palau Community College (PCC) continue their undergraduate or graduate education at UOG. In Fall 2021, just 9 students from NMC and 5 from PCC enrolled at UOG. PCC offers the Associate of Community and Public Health program, featuring courses like Principles of Epidemiology, which covers epidemiology's foundational principles and their application to disease distribution and determinants in populations. Another course, Epidemiological Surveillance & Public Health Information System, focuses on the basics of epidemiological surveillance for monitoring infectious pathogens. Similarly, the Science, Math, Health & Athletics department at NMC offers courses such as Introductory Statistics, Introduction to Programming, and Database Applications. Students from these programs are well-positioned for data science training and further education at UOG. Significance The establishment of the Data Science Center will create infrastructure for data curation, analysis, and science training, fostering increased collaboration among UOG faculty and students, as well as with their counterparts in the Micronesia region. Research Design and Methods Our proposal builds upon the achievements of the PICPCHE REC, the Biostatistics Cores, and the UOG Division of Mathematics and Computer Science (DMCS), and UOG's long-standing commitment to undergraduate research and student mentoring. Dr. Badowski, co-leader of the PIPCHE Biostatistics Core, has successfully mentored 27 students, supported by PIPCHE or other programs, to notable achievements: one completed a PhD, while 12 obtained MS degrees in Statistics or Data Science. These students presented at 29 research conferences. She also led a Problem Based Learning workshop for students from Japan's Shibaura Institute of Technology. Dr. Aquino, DMCS chair and the first CHamoru woman to earn a PhD in Mathematics, has significantly contributed to undergraduate math research for underrepresented minorities through programs funded by Mathematical Association of America (MAA), NASA-funded Established Program to Stimulate Competitive Research (EPSCoR), and National Science Foundations (NSF). Along with DMCS faculty, she has mentored over 30 students in the summer Research Experience for Undergraduates (REU) programs over the past four years. Additionally, the plan for the Data Science Center aligns with UOG’s strategic plan, “Para Hulo’”—the CHamoru phrase for “Ever Upward.” This plan positions the university as a research institution grounded in island wisdom. Aim 1. Establish the first regional Data Science Center at the University of Guam. The Data Science Center, to be established at UOG, will feature advanced workstations and laptops designed for big data analytics. MS in Data Science students will intern at the Center, collaborating with UOG researchers and/or government health agencies, such as the Guam Department of Public Health and Social Sciences, Guam Behavioral Health, Guam Memorial Hospital Authority, and Bureau of Statics and Planning. Their involvement will include contributing to new research proposals, focusing on statistical methodologies and power calculations, and participating in data analysis for manuscript preparation, with the goal of earning co-authorship on submissions. This Center aims to enhance research skills and offer experiences particularly beneficial for those interested in addressing cancer health disparities in the Pacific, among other data science applications. Our commitment extends to developing a diverse workforce proficient in data science, especially within healthcare contexts. By integrating students into active research projects, we aim to provide substantial hands-on experience and mentorship, nurturing their development into skilled professionals. The aim 1 of our proposal fulfills objective 1 of FOA: “Grow human capital with data science competencies, such as knowledge, skills, abilities, and behaviors.” Evaluation and Sustainability: For our first cohort, starting Fall 2024, we aim for 6-8 students in the program, all expected to complete their internships at the Data Science Center and graduate within 2 years. The next cohort is set to begin in Fall 2026. UOG boasts a diverse research portfolio, supported by grants from various agencies, including the NSF-funded EPSCoR-GECCO grant, the NCI-funded Pacific Island Partnership for Cancer Health Equity (U54-PIPCHE) grant, the NOAA-funded Sea Grant, USDA-funded Land Grant programs and projects, CEDDERS funding, and NASA EPSCoR Research Infrastructure Development funding. We plan to continue seeking these grants to support our graduate data science students. Additionally, some students will have the opportunity to apply for teaching assistantships positions at UOG College of Natural and Applied Sciences. Aim 2. Establish infrastructure, security protocols and agreements necessary for the data linkage between Guam Cancer Registry and Medicare, Medicaid and MPI. In Year 1, with the help of PIPCHE IT Shared Resource Core and UOG Office of Information Technology, we will collaborate with the Guam Cancer Registry and the Guam Department of Public Health and Social Services (DPHSS) to: • Establish data sharing agreements with DPHSS and Guam Cancer Registry. • Establish a secure infrastructure for data transfer and storage at UOG. In partnership with UOG's Office of Information Technology (OIT) and the Micronesian Data Laboratory, we aim to utilize expertise and best practices to create a secure, on-site data storage system compliant with NIST and NIH data management policies. This initiative will also enhance our ability to manage healthcare data and offer computer science internships with OIT, further supporting this project. • Prepare secure protocol for the data transfer directly from Guam Cancer Registry (GCR) and DPHSS. As we establish data sharing agreements with GCR and DPHSS, we will establish the protocols and determine the best methods for secure transfer of data from GCR and DPHSS to UOG based on nature and format of the data. Given that the database will temporarily store personally identifiable patient information, it's crucial to meet HIPAA standards for data storage and transmission. We will adhere to HIPAA compliance in all our protocols. Our strategy includes hosting the database behind the OIT’s firewall to limit access, monitor all traffic, and encrypt database backups before storage. In Year 2, for the data linkage, we will use 2007-2022 GCR data, which includes a total of 5,728 cases recorded during that period. We will link the individuals documented in the GCR with their corresponding Medicare, Medicaid, and MIP enrollment data using the Link Plus Software, which is available at no cost from the CDC. It uses a deterministic algorithm based on social security number (SSN), name, sex, date of birth, and, if applicable, date of death. We will also use this opportunity to include noncancer controls, a random sample of Medicare, Medicaid, MIP beneficiaries that are not included in GCR data. To protect the identities of the cancer patients and noncancer controls included in this data, personally identifiable information that is used to link the GCR and Medicare data (eg, SSN, names, and full date of birth) will be removed from the integrated database after the linkage is completed. Instead, each beneficiary will be assigned a unique, nonidentifiable number, which will allow the same individual to be tracked across data files and time. This aim of our proposal addresses Objective 2 of FOA: “Develop or expand infrastructure to support data science research, training, and education” by creating the rich cancer data set that researchers can use for creating hypotheses, or as preliminary data source. The integrated GCR-Medicare database will serve as a valuable resource for researchers. It will contain patient demographics (e.g., age, race-ethnicity, sex), comprehensive clinical cancer details (e.g., diagnosis date, site, histology, stage), and detailed health-care use and cost information that will allow for the identification and comparison of cancer treatment and outcomes across different populations within the dataset. Its longitudinal structure, capturing data before and after a cancer diagnosis, will enable the analysis of time-dependent measures like comorbidity indices, multi-course treatments (e.g., surgery, radiation, systemic therapy), and outcomes such as time to a subsequent event or death. Additionally, this database can also support student training by serving as a practical dataset for educational purposes. Impact and Sustainability. The integration of GCR and Medicare datasets, encompassing social factors, risk factors, and cancer treatment data, will markedly improve both the quality of research and the depth of manuscripts derived from this data. It will aid in identifying the causes of disparities and generating hypotheses for future research. Upon establishing data transfer agreements and data storage infrastructure, we can periodically update the linkage, every two years. Aim 3. Build data science education and training partnerships with the Northern Marianas College (NMC) and Palau Community College (PCC). We plan to hold a two-week workshop titled "Introduction to Data Science with R" in Saipan and Palau, targeting community college and high school students, as well as faculty members, with a cap of 8 participants per location. This beginner-level course emphasizes practical engagement and doesn’t require any prior background, utilizing the open-source software R. Initially, attendees will be guided through the installation of R, its tools, and RStudio. Participants will be given access to de-identified datasets from PIPCHE, research projects, GCR, and Guam BRFSS, enabling them to construct and apply a framework for statistical analysis. The course is structured into six modules. The first module introduces cancer and health disparities research, using findings from PIPCHE to guide students in formulating their research questions. It will also use some of the lectures developed for the new graduate course Cancer Disparities (funded by U54). Module 2 focuses on data visualization using R, covering the basics of ggplot and presenting examples of various graphs such as histograms, bar plots, violin plots, and scatter plots along with attached R scripts on how to run these in R. Subsequent modules (3 to 5) will cover descriptive statistics, linear regression, and logistic regression, respectively. These sections include lab exercises for interpreting results from provided sample data and executing analyses using attached R scripts. In the final module, Module 6, participants will brainstorm research ideas and collaborate in groups, fostering an environment of collective learning and innovation. Course Objectives: 1. Understand how to properly prepare datasets for use in computing workspaces. 2. Understand disparities in cancer and cardiovascular-related risk factors and outcomes. 3. Recognize and articulate a research problem. 4. Describe some models used in data science and the benefits and limitations of these approaches. 5. Gain hands-on experience coding in R and analyzing data sets gathered in past PIPCHE projects. 6. An increased proficiency of student research skills including those used in: literature review, understanding ethical issues, using computer software, and oral and written communication of data science research. 7. An awareness of career options in academics, industry, and/or government. Evaluation and Sustainability. The workshop's evaluation will adopt a formative and summative approach, aiming to gather feedback on the current program's quality and guide improvements for future workshops. The evaluation will be twofold: 1. Students’ self-evaluation, conducted before and after the workshop. 2. Students’ assessment of their workshop experience. The surveys will assess students' perspectives on several key areas, including their understanding of data science career paths, skills in interpreting results, resilience in overcoming research obstacles, preparedness for advanced research, comprehension of knowledge construction, grasp of the research process, insight into how data scientists tackle real-world problems, and proficiency in data analysis. A pre/post evaluation design will be implemented to gauge self-reported improvements in participants' skills and knowledge following their participation in the program. The evaluation will include questions such as: 1. How satisfied were participants with the program overall? 2. Did the research experience meet participant expectations? 3. Did the research experience impact participant plans to pursue career in data science? 4. To what extent did participants increase their research skills during the program? 5. To what extent do participants feel they gained knowledge about the research process? 6. What changes should we make to the program for next year? Aim 3 of our proposal meets the third objective of the supplement program, “Build data science partnerships” particularly focusing on the second point: “Activities that establish learning communities to help participants such as students, educators, and community partners to develop data science identity, equitable data practices, and sense of belonging to the data science community.” For each workshop, our plan includes recruiting one faculty member from each participating institution. In the first year, this faculty member will acquire the necessary skills and knowledge; in the second year, they will help co-facilitate the workshop, gaining hands-on experience in conducting a data science workshop. We will provide these faculty members with all the workshop materials, enabling them to independently run the workshop in the future, even beyond the duration of the supplement. Additionally, we aim to support one student from Saipan and one from Palau in submitting an abstract to a national conference and presenting their research during the second year of funding. This effort is intended to motivate students to pursue further education in data science. Furthermore, while in Saipan and Palau, we plan to engage with the leadership of both institutions to explore creating pathways for students to continue their studies at UOG. REFERENCES 1. Aguon A, Dulana LJ, Teria R, Cruz A, Jin SB, Badowski G. A trend analysis of cancer incidence in Guam from 2002-2018 [abstract]. In: Proceedings of the 16th AACR Conference on the Science of Cancer Health Disparities in Racial/Ethnic Minorities and the Medically Underserved; 2023 Sep 29-Oct 2;Orlando, FL. Philadelphia (PA): AACR; Cancer Epidemiol Biomarkers Prev 2023;32(12 Suppl):Abstract nr B117. 2. Badowski G, Teria R, Dulana L, Aguon C, Wilkens L, Shvetsov Y, Novotny R, Leon Guerrero RT; Abstract 6493: Ethnic disparities in breast cancer survival in Guam. Cancer Res 1 April 2023; 83 (7_Supplement): 6493. https://doi.org/10.1158/1538-7445.AM2023-6493. 3. Leon Guerrero RT, Badowski G, Yamanaka A, Blas-Laguana M, Bordallo R, et al. University of Hawai'i Cancer Center connection: The vital role of cancer registries in the recruitment of an understudied minority population into a breast cancer study: Breast Cancer Risk Model for the Pacific. Hawaii J Med Public Health. 2014 Oct;73(10):335-40. PubMed PMID: 25337453; PubMed Central PMCID: PMC4203456. 4. National Cancer Institute, Division of Cancer Control and Population Sciences, Healthcare Delivery Research Program. Search SEER Linkage Publications https://healthcaredelivery.cancer.gov/publications/. Accessed March, 2024. 5. Enewold L, Parsons H, Zhao L, Bott D, Rivera DR, Barrett MJ, Virnig BA, Warren JL. Updated Overview of the SEER-Medicare Data: Enhanced Content and Applications. J Natl Cancer Inst Monogr. 2020 May 1;2020(55):3-13. doi: 10.1093/jncimonographs/lgz029. PMID: 32412076; PMCID: PMC7225666. 6. Shin D, Fishman MDC, Ngo M, Wang J, LeBedis CA. The Impact of Social Determinants of Health on Lung Cancer Screening Utilization. J Am Coll Radiol. 2022 Jan;19(1 Pt B):122-130. doi: 10.1016/j.jacr.2021.08.026. PMID: 35033299; PMCID: PMC8820269. 7. Yu Z, Yang X, Guo Y, Bian J, Wu Y. Assessing the Documentation of Social Determinants of Health for Lung Cancer Patients in Clinical Narratives. Front Public Health. 2022 Mar 28;10:778463. doi: 10.3389/fpubh.2022.778463. PMID: 35419333; PMCID: PMC8995779. 8. Marron, J. Implementing the Health Insurance Portability and Accountability Act (HIPAA) Security Rule: A Cybersecurity Resource Guide. https://doi.org/10.6028/NIST.SP.800-66r2. Accessed March 2024. 9. NIH, Data Management and Sharing Policy, https://sharing.nih.gov/data-management-and-sharing- policy. Accessed March 2024.